Opioid-induced dysregulation of cortico-striatal circuits

Project Summary/Abstract
Opioid-based drugs are mainstays for pain management despite the risk of dependence, addiction, and
cognitive impairments, even when taken as directed. Yet, the neurological underpinnings of opioid addiction
remain relatively under-investigated, thereby limiting our understanding of the neural and associated
psychological basis of addiction to opioids. Impaired decision-making, strong perseverance and an extraordinary
motivation to obtain drug are widely seen as core aspects of addiction. These behaviors are expressed only by
a fraction of those exposed to the drug – highlighting a significant degree of individual variability and a need to
identify largely unknown factors that convey risk or resilience. Hypofunction of prefrontal circuits has emerged
as a primary mechanism by which this transition occurs, however evidence regarding the nature, sub-circuit(s)
locus, and development of this hypofunction is lacking. Our published data find that self-administration (SA) of
the potent opioid, remifentanil (Rem), promotes a progressive hypoactive state in prelimbic cortex (PrL)
pyramidal neurons that underlies impairments in cognitive flexibility, and that this phenomenon occurs on a faster
timeline in females. Pilot data indicate inflexibility aligns with increased perseverative drug seeking and
motivation for drug that is more prominent in females. We predict these changes emerge as a result of changes
in PL-Core circuits, as pilot data indicate that hypoactivity is more prominent in PrL-Core PN and that this
plasticity aligns with sex- and cell-type specific adaptations in synaptic strength at downstream Core medium
spiny neurons (MSNs) based on expression of dopamine type I (D1) versus type II (D2) receptors. This proposal
will combine circuit-specific ex vivo measures of plasticity, in vivo Ca2+ imaging, and chemogenetics with a novel
SA model that permits longitudinal assessment of individual variability in the development of motivated and
perseverative drug-seeking and a clinically relevant operant model to assess cognitive flexibility (strategy
shifting) to identify changes from synapse to function to behavior. Aim1 of this proposal will further investigate
exposure dependent changes within PrL-Core circuits using pathway-specific ex vivo electrophysiology.
Intersectional chemogenetic manipulations will assess the contribution of this circuit flexibility and drug seeking
and whether dysfunction underlies deficits in flexibility and changes in perseverance/motivation. Aim2 will use
Ca2+ imaging to examine the corresponding disruptive effects of opioid plasticity on PrL-Core information
processing associated with decision making and measure longitudinal changes in basal states and activity
encoding opioid taking with progressive SA. Aim 3 will identify synaptic modifications at PrL-Core D1- and D2-
MSN synapses. Contralateral chemogenetic targeting will determine contributions of PrL-to-D1-MSN and PrL-
to-D2-MSN circuits in flexibility and longitudinally determine if contributions to opioid taking and behavior shifts
over time. Proposed studies will provide novel insight into progressively developing changes in function and
behavior, with the potential to inform more tailored treatments based on sex and stage of addiction.

Public health relevance
PROJECT NARRATIVE The incidence of reported heroin use and nonmedical prescription opioid use is on the rise in recent years, with the rate of abuse in women increasing to a greater extent. The proposed studies will use a variety of techniques to identify how opioids disrupt function of brain regions responsible for cognitive flexibility and control over drug seeking behavior to identify substrates for the transition to opioid addiction and how factors such as biological sex influence development of these functional adaptations.